Role of allergen-driven epithelial genes in asthma pathogenesis

Allergic diseases continue to pose a significant public health burden in modernized societies. Although the etiology of allergic diseases is unknown, they are thought to develop as a result of aberrant Th2 immune responses in genetically susceptible individuals. Despite this recognition, the factors driving Th2-mediated immune responses have remained elusive. Our preliminary data suggests the novel paradigm that allergen exposure induces epithelial cell injury which results in the release of an epithelial-derived factor, trefoil factor 2. Tff2, in turn induces the release of the

Public health relevance
Although allergic diseases have long posed a significant public health burden, the factors predisposing some individuals to the development of these disorders are unknown. Herein, we will test the novel hypothesis that dysregulation of the production of an epithelial-derived factor. Trefoil factor 2, drives susceptibility to allergic disorders through a pathway involving the